Using strain history to improve prediction of the evolution of antimicrobial resistance in Acinetobacter baumannii

PROJECT SUMMARY
The objective of this proposal is to gain a more complete understanding of the influence of evolutionary
history on the predictability of evolution. Understanding predictability and repeatability of evolution has long been
a goal of evolutionary biologists. Applying these questions to the field of antimicrobial resistance (AMR) provides
the benefit of obtaining clinically relevant results while also studying questions that are fundamental to
evolutionary biology. AMR is a rapidly worsening global health issue, with an increasing number of bacterial
infections becoming impossible to treat with most drugs. Of serious concern is Acinetobacter baumannii, a
nosocomial and highly multidrug resistant (MDR) pathogen. Although resistance is often attained through
common pathways, such as increased drug efflux and modifications to the drug target, it remains unclear how
evolutionary history affects the evolution of AMR, and to what degree or level resistance evolution is predictable.
History (such as genetic relatedness and previous antibiotic exposure) is an underappreciated aspect that
influences evolution and can have lasting effects on the genome that alter or constrain paths available for
adaptation to antibiotic stress.
To address these gaps in knowledge, we propose to use a preexisting collection of A. baumannii clinical
isolates. The first aim of this proposal focuses on understanding the genetic and phenotypic differences within
these isolates, with special focus on virulence and resistance. Through comparative genomics we will identify
sequence similarity as well as pan-genome composition. We will use known causes of resistance, compiled from
previous studies in the Cooper Lab and others, to create a genome based multi-locus predictor of resistance
phenotypes. We will combine the comparative genomics analysis with results of phenotypic assays for biofilm
formation, growth in different conditions, and persistence, to assess any phylogenetic phenotypic patterns. We
will verify select gene-phenotype associations through molecular engineering, helping to detangle the genotype-
phenotype map of A. baumannii. The second proposed aim will further enhance our knowledge regarding the
predictability of resistance evolvability. We will evolve 20 clinical isolates in the presence of the ribosome-
targeting drug, tigecycline, and monitor the corresponding fold increase of resistance, with the prediction that
initial resistance level will dictate final evolved resistance level. Through whole population, whole genome
sequencing, we will be able to assess the level of predictability to which resistance evolution occurs genetically.
Completion of this project will not only provide answers to broad evolutionary questions but will also be
a crucial step in the fight against the antimicrobial resistance crisis. We will make conclusions as to what level
AMR is predictable mechanistically. A greater understanding of predictability will have direct clinical importance
and allow for personalized therapeutic strategies for the treatment and prevention of MDR infections.

Public health relevance
PROJECT NARRATIVE This project will increase the understanding of the evolutionary predictability of antimicrobial resistance for the high-priority nosocomial pathogen, Acinetobacter baumannii. Using clinical isolates, the research proposed in this application will increase translational predictive measures of resistance adaptability, demystify the genotype- phenotype map of virulence and resistance associated phenotypes, and clarify the genetic level to which resistance evolution is predictable. The results will guide future treatment optimization and be applicable to other multidrug resistant bacterial pathogens.